Resource Section

PROJECT SUMMARY
This application proposes a renewal of the Mouse Mutant Resource and Research Center (MMRRC) at The
Jackson Laboratory. Highly sophisticated genome engineering technologies, a well-characterized genome,
mammalian physiology and economical husbandry requirements make laboratory mice the mainstay of
biomedical research into disease mechanism and for disease modeling. The NIH has recognized that the
potential impact of genetically engineered mice for biomedical research cannot be fully realized without a
centralized effort to identify, archive, evaluate, characterize, and distribute valuable strains of mice to qualified
biomedical researchers. The MMRRC provides this centralized repository function. With 90 years of mouse
genetics and mouse resource experience, The Jackson Laboratory joined the MMRRC in 2009 and remains a
key member of the consortium. This proposal requests on-going support for The Jackson Laboratory as one of
the four MMRRC core repositories. As a member of the MMRRC consortium, the Jackson Laboratory will
contribute to the development and improvement of consortium-wide standard operating procedures. The
MMRRC at JAX will follow these mutually agreed upon standard operating procedures in its efforts to import,
archive (through cryopreservation of sperm and/or embryos) and distribute biomedically important strains of
mice and related materials. The MMRRC at JAX will also provide related services on a fee for service basis
and will conduct high-risk, high-return research projects that augment the overall goals of the consortium.